Uniformed Services University of the Health Sciences (USU)

The NIH NeuroBioBank (NBB) is a trans-NIH initiative that supports programs to acquire post-mortem human brain and nervous system tissue, process, appropriately store, and distribute to researchers to support research into diverse brain functions and disorders, including neurodevelopmental, neurologic and neuropsychiatric diseases. Whole genome sequencing (WGS) of NBB samples will facilitate the identification of genomic variants associated with the different clinical diagnoses represented in the NBB collection. Understanding of genomic variants that result in the loss of function of genes or the occurrence of structural variants, is expected to have two benefits. (1) Understanding the genetic landscape may inform previous studies that have used NBB samples. (2) Analysis of genetic variation may lead to the discovery of variants that cause brain disorders.